Mitochondrial dynamics underlying oligodendrocyte generation

PROJECT SUMMARY
Myelin has evolved to speed up, finely tune, and increase the metabolic efficiency of electrical signal transmission
in the brain. In numerous human diseases, myelin degenerates, ultimately resulting in devastating motor and
cognitive impairment. One key reason that this degeneration progresses to functional impairments is the decline
in the ability of resident oligodendrocyte precursor cells (OPCs) to generate new myelinating oligodendrocytes
and replace the dying cells. To generate new oligodendrocytes, OPCs go through many cellular and molecular
checkpoints, coordinating external microenvironmental signals with internal genetic, epigenetic, and metabolic
states. Given this complexity, there are still many questions related to how these signals are integrated within
the cell to ultimately result in the cell fate decision to transform into a postmitotic myelinating oligodendrocyte or
remain a proliferative OPC. Mitochondrial activity has been shown to play important roles in similar fate decisions
in other cell types throughout the body in addition to playing major roles in cell death pathways, however, less is
known about how these organelles impact OPC fate, oligodendrocyte generation, and oligodendrocyte death in
the intact brain. To directly study this, we have developed advanced techniques for high resolution imaging and
manipulation of mitochondria throughout the oligodendrocyte lineage. These techniques permit longitudinal
analyses of mitochondrial structure, localization, and dynamics in real time all in the live mammalian cerebral
cortex. Here we propose to use these approaches to determine how disruptions and alterations in mitochondrial
dynamics, characterized by mitochondrial fission, fusion, motility, generation, and degradation, impact OPC fate
and oligodendrocyte survival. These experiments will be performed in the context of development, adulthood,
aging, and in demyelination models, thus revealing the precise role mitochondria play in oligodendrocyte
generation, plasticity, death, and regeneration. Ultimately, these studies will reveal multiple aspects of cell
metabolism with a mitochondrial lens providing a critical foundation to understand this multifunctional organelle
in oligodendrocyte physiology and pathology.

Public health relevance
PROJECT NARRATIVE Myelinating oligodendrocytes are generated throughout life, a process that fails in aging and disease potentially due to altered cell metabolism. To investigate this feature, we have developed advanced methodologies for visualizing mitochondria morphometrics and dynamics across the oligodendrocyte lineage in the live brain. Using these tools this project will investigate how and when mitochondria shape, localization, and function impact oligodendrocyte development, death, and regeneration.